Understanding the impact that tumor representative oxygen tension has on phosphotyrosine-dependent signaling networks in solid tumors

PROJECT SUMMARY/ ABSTRACT
The perturbation of phospho-tyrosine mediated signaling networks is an essential occurrence during the
multistep process of tumor development and progression. As a result, the components of these phospho-tyrosine
signaling networks, especially tyrosine kinases, have been shown to be a key reservoir of actionable molecular
targets for the treatment of cancer. In recent years, it has been revealed that the tumor microenvironment plays
a critical role in modulating the signaling pathways that govern tumor progression and metastasis. The features
of a tumor's microenvironment have been shown to produce unique sensitivities and resistances to different
treatment modalities. One major aspect of the tumor microenvironment which is often overlooked in preclinical
studies is oxygen tension. This proposal seeks to understand the impact that oxygen tension has on
phosphotyrosine-dependent signaling networks in solid tumors, and how the resultant vulnerabilities can be
targeted to improve patient outcome. In Aim 1.1 (prior studies), we sought to identify alterations in signaling
networks that occur when lung cancer cells colonize the brain, a hypoxic environment. We showed that brain-
metastatic lung cancer cells elevate and have an increased dependence on a non-canonical HSF1-E2F
transcriptional program for survival. Importantly, we identified that this transcriptional program is targetable
through treatment with allosteric ABL2 tyrosine kinase inhibitors. In Aim 1.2 (proposed studies), using a small
molecule screen, I have identified previously unrecognized modulators of the cellular response to hypoxia, a
tumor microenvironment feature associated with increased metastasis and lower overall survival in patients with
solid tumors. The top uncharacterized hit was the FDA-approved ABL1/2 tyrosine kinase inhibitor Dasatinib and
my preliminary investigation has shown that the ABL kinases are critical regulators of HIF-1α protein stability. I
will continue mechanistic investigation of the ABL- HIF-1α axis in vitro and in vivo. Finally, in Aim 2 (post-doctoral
studies), I will focus on understanding the impact that tumor representative- oxygen tension has on protein
tyrosine phosphatase activity. Extensive investigation has demonstrated that tumor hypoxia induces activation
of phospho-tyrosine signaling networks, but current work has almost exclusively focused on the role of tyrosine
kinases. I show that hypoxia induces inhibitory oxidation of protein tyrosine phosphatases (PTPs). Using mass-
spectrometry based approaches, I will identify the oxidized- PTP landscape (ox-PTPome) of tumor samples and
cancer cells at oxygen levels observed in tumors. Further, since PTPs restrain cellular signaling, I will employ
high-throughput drug screening technologies in vitro to identify emergent sensitivities due to the loss of PTP
activity that would not have been captured in the numerous normoxically (tumor-unrepresentative oxygen level)
performed screens. Overall, the focus of my career is to understand how the different characteristics of the tumor
microenvironment, such as hypoxia, modulates the signaling networks co-opted by cancer cells and translate
this to the identification of biological mechanisms that may be amenable to therapeutic exploitation.

Public health relevance
PROJECT NARRATIVE Low oxygen tension, despite being a distinguishing trait of solid tumors, is rarely recapitulated in preclinical cancer research leading to the investigation of less-representative signaling pathways and the omission of hypoxia induced sensitivities and resistances to pharmalogical intervention. This proposal describes completed and ongoing pre-doctoral efforts to uncover actionable targets of tyrosine kinase signaling pathways that emerge during hypoxia and in hypoxic metastatic niches, as well as future post-doctoral efforts to investigate the impact of hypoxia induced tyrosine phosphatase (PTP) inactivation. Further, since PTPs restrain cellular signaling, identification of emergent sensitivities due to the loss of PTP activity may result in the identification of biological mechanisms amenable to therapeutic exploitation that have been not captured in previous normoxic efforts.